Understanding the role of the stromal cell niche in intestinal stem cell aging

Project Summary
Aging compromises the numbers/function of mammalian Lgr5+ intestinal stem cell (ISCs), which depend
on niche factors produced by neighboring cell types like stromal cells. Although the necessity of these niche
factors has been tested in vitro, many uncertainties remain regarding their in vivo sources and the impact of
aging on them. To address these questions, we have focused on RSPO3, the dominant R-spondin in the
mammalian intestine and Lgr5 ligand that drives ISC self-renewal. Using novel Rspo3-GFP mice, we have
discovered that RSPO3 is expressed by two distinct populations in the intestinal stroma: RSPO3+GREM1+
fibroblasts (RG fibroblasts) and lymphatic endothelial cells (LECs). We have established heterotypic co-culture
systems of RSPO3+ stromal cells with intestinal epithelial organoids, and have found that RG fibroblasts, more
than LECs, support organoid growth. Importantly, the numbers/function of RG fibroblasts decline
significantly in old mice. By RNA-seq, we have discovered that S-adenosyl-L-homocysteine hydrolase (Ahcy),
a rate-limiting enzyme in methionine metabolism that hydrolyzes S-adenosyl homocysteine (SAH), is the most
downregulated gene in aged mouse RG fibroblasts compared to their young counterparts. Furthermore,
pharmacological inhibition of Ahcy recapitulates the age-related decline in the ability of RG fibroblasts to support
ISCs, whereas short-term methionine restriction reverses the age-related decline of RG fibroblasts. We
hypothesize that Ahcy loss and methionine accumulation in RG fibroblasts account for some of the age-related
deficits of old ISCs that can be reversed by short-term dietary methionine restriction. In this proposal, we will test
the hypothesis that RG fibroblasts are the dominant niche cells that foster ISCs in vivo (Aim 1); that loss of Ahcy
leads to the age-related decline of RG fibroblasts through accumulation of methionine cycle intermediate
metabolites (Aim 2); and that short-term dietary methionine restriction rejuvenates aged mouse RG fibroblasts
to support ISCs and ISC-mediated regeneration (Aim 3).
Through these aims, we will provide novel insights into how age-related changes in the ISC stromal niche
contribute to ISC aging and how we can reverse it through modulating methionine metabolism. Identification of
a new dietary intervention that may augment intestinal regeneration in old age will have important clinical
implications. My goal is to discover novel insights into how aging influences stem cells with the long-term goal of
translating these findings back to the clinic for the improvement of patient health. Because little is known about
the aging and metabolism of stromal niche cells in ISC biology, the novel tools that I develop and the skill sets I
acquire to assess metabolism of aging stromal niche cells during the K99 training period will permit me to
establish a successful and independent research program as I transition to independence.

Public health relevance
Project Narrative Aging decreases mammalian intestinal stem cell (ISC) numbers, function, and regenerative capacity; however, how age-related changes in stromal niche cells contribute to ISC aging remains unknown due to the lack of experimental tools. Here, we develop new heterotypic organoid co-culture systems and novel mouse models to investigate how stromal niche cell aging influences the biology of ISCs. We will further interrogate how short- term dietary methionine restriction can modulate the stromal niche cells to enhance ISC function and intestinal regeneration in aging.